NATIONAL TOXICOLOGY PROGRAM ARCHIVES

The purpose of this contract is to provide storage and retrieval for all of the histological slides, paraffin blocks, formalin-fixed wet tissues, paper data, and microfiche/microfilm for the toxicity and carcinogenicity studies conducted by the Program. In addition, the contractor will be required to provide space and personnel to assist NTP audit support contractors; provide space and personnel to photograph lesions; provide space and personnel to evaluate pathology data prior to quality assessment; coordinate pathology data; microfilm data; establish and maintain a frozen tissue bank; provide capabilities for processing and preparing up to 1,000 routine histology slides per month from archive tissues and blocks; and, provide pathology expertise for consultation with Program and contractor pathologists concerning data generation and correction of problems established by the Pathology Data Review.